Proteomics Core Facility Shared Resource

ABSTRACT – PROTEOMICS SHARED RESOURCE FACILITY
The mission of the Proteomics Shared Resource Facility is to provide cost-effective, state-of the-art
instrumentation and analytical proteomics expertise to investigators in the Lurie Cancer Center (LCC). The
Proteomics Core provides a full array of services including study design, sample preparation, data generation
and analysis and interpretation of results. The Core supports work involving the following types of
methodologies: 1) protein identification from gels and BioID samples. 2) Quantitative proteomics – labeled and
label-free. 3) Top-down proteomics - qualitative and quantitative, 4) Site-specific PTM analyses, including
phosphorylation, acetylation, methylation, glycosylation, palmitoylation, and ubiquitination; 5) Targeted
proteomics using selective reaction monitoring (SRM) and related methods; 6) Histone Modification Panel
analysis, covering all major histone marks, and 7) Advanced proteomics sample preparation from body fluids
(blood, urine, saliva, CSF), tissue, secretome, exosome, and mitochondria. In addition, the Proteomics Core
staff provides education and training in sample preparation, instrumental analysis and data analysis to LCC
investigators and their laboratory personnel. The Core operates eight liquid chromatography-mass spectrometry
systems and since its inception as a former developing core at the time of the last CCSG review, has served
over 90 LCC investigators, resulting in over 60 research publications.
The Proteomics Core is located on both campuses of Northwestern University (NU). Neil Kelleher, PhD, directs
the Facility and works closely with Young Ah Goo, PhD, the Operations Director of the Facility. As a cross-
university, cross-campus resource, access to service is available to all Northwestern University investigators,
with priority given to LCC researchers. During the next funding period, the Proteomics Core will continue to work
closely with LCC researchers to ensure that efficient access and technological expertise in proteomics is
available to all research teams engaged in basic, clinical and translational cancer studies.